Administrative Core

Administrative Core
Center for Bio-behavioral Mechanisms of Eating Behavior
PROJECT SUMMARY/ABSTRACT
The primary goal of this application is to strengthen biomedically oriented clinical research in the area of
eating disorders and eating behaviors at the Sanford Center for Bio-behavioral Research. The proposed
Center for Bio-behavioral Mechanisms of Eating Beahavior (CBM-EB) will focus on the study of bio-
behavioral mechanisms in eating disorders and problematic eating behavior, including obesity. The CBM-EB
will be based in Sanford Center for Bio-behavioral Research and also include the UND School of Medicine
and North Dakota State University. In addition to establishing an enduring clinical research center which
addresses serious psychiatric disorders like eating disorders, as well as problems related to obesity, a major
function of the center will be to train and support early stage investigators in their efforts to become
independent scientists. The Center will require integrated administrative oversight to ensure excellent training
opportunities and optimal functioning of several of the core elements in the Center. The overall goals for the
Center can be characterized with the following set of specific aims. Aim 1 will be to establish an enduring
center of excellence in eating disorders and eating behavior that will facilitate research on clinically relevant
mechanistic processes at the Center for Bio-behavioral Research. Aim 2 will be to establish three research
cores and a clinical research training program to foster scientific and educational progress. Aim 3 will be to
provide broad based clinical research training, professional development, and mentorship to five early career
investigators.